Dissemination and Implementation Science Core

PROJECT SUMMARY/ABSTRACT - DISSEMINATION AND IMPLEMENTATION SCIENCE CORE
The primary goal of the new Dissemination and Implementation Science Core (DISC) is to provide NORC
investigators with support integrating dissemination and implementation (D&I) science into their nutrition and
obesity-related research programs. The D&I of biomedical discoveries is challenging but an absolute necessity
to ensure all populations benefit from investments in nutrition and obesity research, and close the gap between
biomedical discovery and evidence-based practices, interventions, and policies. The DISC will help NORC
investigators develop the knowledge and skills needed to apply state-of-the-art D&I science to their research
programs through the following two specific aims. Aim 1 will provide individual consultation and training in D&I
scientific methods for nutrition and obesity research through which we will: a) conceptualize and design
implementation science studies, b) develop a dissemination plan for studies, c) ensure efficient use of D&I
web-based toolkits and other resources, and d) conduct manuscript and grant application reviews. Aim 2 will
build team capacity in the broad range of skills essential for D&I research. To accomplish this aim we will: a)
engage NORC investigators in the Washington University Network for Dissemination and Implementation
Research (WUNDIR), a regular (every 6 weeks) event that addresses methodological and conceptual
challenges of research grants and publications that involve D&I science and fosters transdisciplinary team
science; and b) coordinate biannual day-long Next Steps events, in which NORC investigators form
collaborative teams to develop manuscripts and/or grant proposals that incorporate D&I science into nutrition
and obesity research. The application of D&I science to T1 and T2 research provided by the DISC is cutting
edge in support of the earliest phases of translational research, which will accelerate the translation of
knowledge from NORC discoveries to real-world settings, and improve the potential for equitable impact on
population health.